A 400MHz NMR Spectrometer

A 400 MHz NMR Spectrometer
The Analytical Resources Core (ARC) at Colorado State University is requesting funds
to purchase a new 400 MHz NMR spectrometer to expand the capacity of our NMR
facility for routine 1D and 2D NMR data collection by undergraduate and graduate
student researchers and postdoctoral associates in the chemical sciences. The current
NMR systems in the ARC can no longer support the growing number of researchers
who need daily access to 400 MHz NMR due to recent growth in research programs
and new faculty hires in synthetic chemistry all of whom will rely heavily on NMR to
operate their research programs. The instrument will be managed within the ARC that is
a Colorado State University institutional shared use Core facility homed in the Office of
the Vice President for Research. The instrument will be located in the ARC’s NMR
laboratory in the Chemistry Research Building, home to all the synthetic chemistry
research groups at CSU. At the present time, we do the greatest portion of our routine
NMR work on two walkup 400 MHz Bruker NMR systems. One of these lacks
automation limiting high throughput sample analysis. The other system is
oversubscribed with usage in excess of accessible user time. The proposed 400 MHz
NMR will support full automation and be equipped with a sample changer and an
automated high performance broadband probe. The magnet solenoid will be actively
shielded, have a long hold helium Dewar and will be fully equipped with a helium
recovery system. Recovered helium will be purified and reliquefied on the ARC’s helium
liquification system making this spectrometer a highly efficient and sustainable system
in the current uncertain helium supply environment. The combination of magnet field
control, console technology, broadband probe, sample changer and advanced software
will provide required sensitivity, resolution and performance to the NIH-supported
research at CSU.
The new 400 NMR will serve NIH and other funded projects involved with synthesis,
catalysis, chemical biology, medicinal chemistry, sustainable polymer chemistry,
nanoparticle design for biological imaging and many others. There are five NIH projects
supported by this proposal and a similar number of projects funded by other agencies or
CSU new faculty startup funds.

Public health relevance
A 400 MHz NMR instrument system equipped with an efficient shielded superconducting magnet, a broadband probe, a 60 slot autosampler and a helium recovery system is proposed to be purchased by Colorado State University. The instrument will be operated and maintained in the University shared use Analytical Resources Core. This instrument provides important data that is used by NIH funded scientists to discover chemical matter used for application in human health such as providing new chemical tools for drug development and biological imaging.